INTRAVENOUS AMONAFIDE FOR PATIENTS WITH SOLID TUMORS REFRACTORY TO THERAPY

The purpose of this study is to determine the safety, tolerance, pharmacokinetic profile, biological effects, and maximally tolerated dose of amonafide administered by intravenous infusion, once weekly on a 4-weeks on/1 week off schedule to patients with histologically documented advanced malignancies resistant or nonamenable to conventional therapy.